EARLY MARKERS OF ALZHEIMER'S DISEASE IN LONGITUDINAL PARTICIPANTS

Participants in the Baltimore Longitudinal Study of Aging aged 60 and older were examined to detect changes in psychological, neurological, and neuropsychological tests related to early signs of Alzheimer's disease. Six-year changes in immediate visual memory performance assessed by the Benton Visual Retention (BVR) test were used to predict Alzheimer's disease (AD). The subjects of this study were 279 community-dwelling adult participants in the Baltimore Longitudinal Study of Aging, eight of whom received AD diagnoses from a neurologist based on DSM III-R and NINCDS- ADRDA criteria. Subjects with diagnoses of AD had disproportionately larger changes in numbers of errors over the six-year retest interval prior to estimated onsets than subjects without AD diagnoses. In addition, significant risk for AD was associated with changes in BVR performance from a proportional hazards analysis. The relative risk for AD associated with six-year BVR changes of six errors was 5.9 (95% CI=5.0-7.1). These results suggest that symptoms of AD may be manifested by changes in immediate visual memory performance earlier than is detectable by clinical evaluation.